Multilevel Characterization of Approach and Avoidance Biases Linked to Social Stress

PROJECT SUMMARY
People experiencing major depression often decline their approach to rewards, to instead avoid threats (including
irrelevant ones). Despite the prevalence of these costly behaviors featuring decision-making impairments, their
underlying neurobiology is poorly defined. Here, I combine powerful mouse models to provide a multilevel
characterization of approach and avoidance decisions linked to depression. Previous studies highlight specific
areas within the corticostriatal-limbic system as signaling approach and avoidance expression. However, I
propose to go beyond this limited approach by unbiasedly profiling neuronal activity in the whole brain of mice
showing approach and avoidance decisional biases linked to depression-related phenotypes. Further, I propose
to unbiasedly profile transcriptional patterns in key areas and to chemogenetically test the role of key cell types.
I hypothesize that, in addition to proven areas, our results will reveal overlooked areas and cell types whose
activity might be crucial in driving approach and avoidance biases linked to depression. Moreover, our
transcriptional analyses will identify proven (i.e., ∆FOSB & CREB) and novel transcriptional regulators driving
these biases. In Aim 1, I adapted a platform-mediated avoidance task, to profile approach and avoidance biases
in mice exposed to chronic social defeat stress (CSDS), a model used to study depression-related pathology. I
first demonstrated that mice susceptible to the CSDS, similar to depressed patients, show persistent avoidance
to a cue previously announcing a shock threat, at the cost of missing rewards. In contrast, mice resilient to the
CSDS quickly decrease their avoidance to maximize gaining rewards. To further characterize these behavioral
biases, in Experiment 1.1, I use brain-wide immunostaining of cFOS as a proxy for correlated neuronal activity.
Next, to leverage neuronal activity and gene expression patterns, in Experiment 1.2, I will use RNA-sequencing
to transcriptionally profile areas whose activity most strongly correlated with approach and avoidance biases.
Simultaneously, I will profile the nucleus accumbens, amygdala, and prefrontal cortex within the corticostriatal-
limbic system, which have been proven to signal approach and avoidance and to be sensitive to the adverse
consequences of stress. Next, in Experiment 1.3, I will perform chemogenetics, to test the causal role of key
areas and cell types in biasing approach or avoidance decisions after CSDS. Capitalizing on this training, in the
K00 phase, I will study in vivo temporospatial dynamics of decision-making circuits sensitive to stress, by
combining behavior with calcium-imaging and computational modeling. The overall training and research plans
outlined here will reveal novel insights into decision-making processes impacted by stress, and will greatly
support my successful transition to a postdoctoral fellowship and subsequent scientific independence.

Public health relevance
PROJECT NARRATIVE Major depression and other stress-related disorders promote severe lack of motivation and despair, leading to a reduced approach to rewards, to persist in avoiding insignificant threats. In this proposal, we characterize these decisional biases at the behavioral, cellular, and molecular levels in mice. Understanding these decision- making biases at multiple interacting levels will reveal significant insights and potential therapeutics targeting specific features of stress-related psychopathologies.